Non-invasive Imaging for Therapeutic Efficacy (NITE) in Ndufs4 Mouse Model of Leigh Syndrome

ABSTRACT
Leigh Syndrome (LS) is a devastating childhood-onset neurodegeneration disease, affecting 1 in
40,000 live births, caused by genetic defects in mitochondrial electron transport chain (ETC) Complex I. More
than 75 genes have been identified for LS, including the nuclear-encoded ETC Complex I subunit NADH
dehydrogenase (ubiquinone) Fe-S protein 4 (NDUFS4, 5q11.2). There is no cure for LS. Current clinical
management for LS is palliative. There is an urgent need for cure.
Large-scale randomized trials are challenging for LS, due to low numbers of patients with defects in the
various genes. While several clinical trials are underway, the absence of robust non-invasive surrogate
endpoints targeting the causal etiology [i.e. impaired ETC Complex I] has hampered their progress. Animal
models have been invaluable in modeling LS and therapeutic development. However, current mitochondrial
functional assays are invasive thus not feasible for in vivo longitudinal evaluation. In addition, different brain
regions could have varied degrees of dysfunction or sensitivity to drug treatments. Furthermore, LS is a multi-
system syndrome, affecting all organs, especially energy-demanding organs like brain, muscle, and heart.
Using death as an endpoint to evaluate therapeutic efficacy, a common practice for animal studies, is not only
time consuming but, more importantly, lacks specificity for multi-system disease as LS. There is a critical
knowledge gap in LS field - lacking in vivo non-invasive and robust tools targeting causal etiology (impaired
ETC Complex I) to evaluate therapeutic efficacy both preclinically and clinically.
The goal of this study is to establish novel Non-invasive Imaging for Therapeutic Efficacy (NITE) for
LS in Ndufs4 knockout (KO) mice. We will test the preclinical utility of 4D Oxy-wavelet MRI as a valid surrogate
endpoint for LS therapy with three types of therapeutic interventions targeting different aspects of LS
pathogenesis: two known established therapies (chronic hypoxia and gene therapy) and one new therapy
(dodecanedioic acid).
In the short term, this project will demonstrate that NITE is a robust and sensitive non-invasive imaging
biomarker of preclinical therapeutic efficacy to accelerate therapeutic screening in animal models.
Furthermore, this project will demonstrate the effect of bypassing an ETC Complex I defect through the
anaplerotic compound dodecanedioic acid (DC12) for TCA cycle that generates succinate, potentially
establishing a novel therapeutic intervention in LS and other Complex I symptomatology. In the long term,
NITE can be optimized for clinical translation for differential diagnosis, prognosis, and clinical trials.

Public health relevance
Project Narrative Leigh Syndrome (LS) is a devastating childhood-onset neurodegeneration disease caused by mutations in the mitochondrial electron transport chain (ETC) Complex I. The goal of this study is to establish novel Non-invasive Imaging for Therapeutic Efficacy (NITE) targeting the causal etiology for LS [i.e. impaired ETC Complex I], and to test its preclinical utility in Ndufs4 knockout mice with three therapeutic strategies.